Development of Innovative and Best Practices in the Implementation of the Retail

Project Summary A summary of the proposed research- Development of Innovative and Best Practices in the Implementation of the Retail Program Standards is listed below: Aim: to develop an effective method to measure Active Managerial Control (AMC) of Foodborne Illness Risk Factors in foodservice operations through the implementation of a PTV Assessment Methodology* that can be duplicated by other agencies The expected outcome of this aim is to provide a means for field inspection staff to quantify the level of AMC of foodborne Illness (FBI) risk factors being demonstrated in a foodservice operation, in order that areas in need of improved risk control can be identified and acted upon. Aim: to develop a feedback mechanism that empowers foodservice managers to continuously improve the level of AMC in their foodservice operation. Achievement of this aim is expected to result in the ability to measure the impact of specific interventions on long-term control of foodborne illness risk factors. Aim: to develop an effective, efficient system of food protection program self-assessment and continuous improvement using the voluntary program standards as the framework. The expected outcome of this aim is a system that supports the ongoing evaluation of program standard elements through reports generated from data that will be maintained electronically (PH-Doc software system). These aims will be achieved through the deployment of strategies that are specific to each of the nine Voluntary National Retail Food Regulatory Program Standards. *PTV Assessment Methodology- a risk-based approach to evaluating active managerial control Developed by Olmsted County Public Health Services Public Health (field inspection) staff evaluate the management system for each FBI risk factor by assessing the P-Policies/procedures, T-Training, and V-Verification elements for each risk factor. Each risk factor is given a rating of 1-5 (1 = non-existent; 5=proactive management) for P, T, and V. This PTV evaluation helps to identify the root cause of an inadequately controlled risk factor and focuses the operator on long-term system improvement in one or more of these management areas (P, T or V).

Public health relevance
Project Narrative The proposed project strategies have significant relevance to the field and practice of public health. One potential outcome associated with these efforts is the increased use of risk-based methodologies in food regulatory programs. Basing food program work on the principles of epidemiology and the protection of the public's health are paramount to our work being viewed as essential. __SpecificAimsTextDelimiter__ Specific Aims The goals and a summary of the proposed research- "Development of Innovative and Best Practices in the Implementation of the Retail Program Standards" are listed below: Aim: to develop an effective method to measure Active Managerial Control (AMC) of Foodborne Illness Risk Factors in foodservice operations through the implementation of a PTV Assessment Methodology* that can be duplicated by other agencies The expected outcome of this aim is to provide a means for field inspection staff to quantify the level of AMC of foodborne Illness (FBI) risk factors being demonstrated in a foodservice operation, in order that areas in need of improved risk control can be identified and acted upon. Short-term Objective: Develop a PTV Field Inspection Guide. Train and standardize to the guide. Intermediate Term Objective: Measure inter-rater reliability in conducting PTV Assessments. Long-term Objective: Develop and implement a quality assurance/audit process for measuring a food protection program's internal capacity to identify inadequately controlled FBI risk factors Impact of results: Increased food protection program capacity to promote long-term control of FBI risk factors Aim: to develop a feedback mechanism that empowers foodservice managers to continuously improve the level of AMC in their foodservice operation. Achievement of this aim is expected to result in the ability to measure the impact of specific interventions on long-term control of foodborne illness risk factors Short-term Objective: Solicit input from foodservice operators regarding the operational barriers to achieving AMC of FBI risk factors Intermediate Term Objective: Develop tools and provide consultation & education that support correction of uncontrolled risk factors Long-term Objective: Promote operator-directed continuous improvement of food safety management systems Impact of results: Increased AMC and decreased occurrence of FBI risk factors in foodservice operations Aim: to develop an effective, efficient system of food protection program self-assessment and continuous improvement using the voluntary program standards as the framework The expected outcome of this aim is a system that supports the ongoing evaluation of program standard elements through reports generated from data that will be maintained electronically (PH- Doc software system). Short-term Objective: Identify reporting and data needs. Intermediate Term Objective: Develop an integrated reporting system that supports program operations and self-evaluation Long-term Objective: Develop and implement a systematic process to continuously improve food protection program performance Impact of Results: Organizational capacity to assess program elements and make adjustments as needed to improve performance-at anytime, rather than relying on an annual or less frequent process for identifying opportunities for improvement. *PTV Assessment Methodology- a risk-based approach to evaluating active managerial control Developed by Olmsted County Public Health Services Public Health (field inspection) staff evaluate the management system for each FBI risk factor by assessing the P-Policies/procedures, T-Training, and V- Verification elements for each risk factor. Each risk factor is given a rating of 1-5 (1 = non-existent; 5=proactive management) for P, T, and V. This PTV evaluation helps to identify the root cause of an inadequately controlled risk factor and focuses the operator on long-term system improvement in one or more of these management areas (P, T or V).